ASSESSMENT OF GLUCOSE METABOLISM AND INSULIN SECRETION

In this study the effect of lactation on insulin sensitivity and insulin release will be ascertained. Prolactin measurements allow the effects of this hormone on the above parameters.